CLINICAL, BIOLOGICAL RISKS FOR DEVELOPMENT OF AIRWAY DISEASE IN GRAIN HANDLERS

Comparison of clinical parameters, lung function, and biochemical indices in grain handlers developing progressive airway obstruction.